Targeting Translation Dependence in Colorectal Cancer Progression

PROJECT SUMMARY
Metastatic colorectal cancer (CRC) is an aggressive disease impacting about 50,000 deaths annually in the
USA. Patients with metastatic CRC are predominantly unresponsive to existing therapies. The metastatic
process is mediated in part by dysregulated translation of oncogenic mRNAs, leading to overproduction of their
encoded proteins. Previous findings established dysregulation of cap-dependent mRNA translation downstream
of mTOR at the level of 4E-BP1/eIF4E as a key to tumor formation and metastatic progression in CRC. While
targeting mTOR is thought to be a promising strategy for CRC therapy, limited therapeutic efficacy of mTOR
inhibitor drugs correlates largely with loss of the translation repressive function of 4E-BP1. More recent findings
indicate that Snail acts as a strong repressor of 4E-BP1 transcription and cooperates with mTOR-mediated
phosphorylation (inactivation) of 4E-BP1 to significantly increase eIF4E-initiated cap-dependent mRNA
translation. These processes support tumor growth and decrease the efficacy of the mTOR kinase (ATP-
competitive) inhibitors (mTORkis) in CRC therapy. Although mTORkis effectively inhibit phosphorylation of 4E-
BP1 and restore its repressive effects on cap-dependent translation and tumor growth, treatment with mTORkis
in CRC cells can promote the active translation and expression of the immunosuppressive protein PD-L1 via
initiation at an internal ribosome entry site (IRES) in a cap-independent manner. In addition, the RNA helicase
eIF4A is a key PD-L1 IRES binding protein that regulates its translation and expression. Importantly, elevated
PD-L1 levels induced by mTORkis result in evasion of anti-CRC immunity. Further, targeted inhibition of PD-L1
can restore T-cell immunity and enhance the efficacy of mTORkis. Based on these findings, the central
hypothesis of the proposed study is that CRC cells usurp the regulatory mechanisms underlying both cap-
dependent translation through co-activation of Snail and mTOR and IRES-mediated translation of PD-L1 to
escape immune surveillance in mTOR kinase-targeted therapy, thereby causing CRC resistance to mTORkis
and promoting CRC progression. To test this hypothesis, the following specific aims are proposed: 1) to identify
how Snail cooperates with mTOR in translational control of CRC progression and modulation of mTOR kinase-
targeted therapy; 2) to determine the cap-independent mechanism of PD-L1 mRNA translation upon mTOR
kinase inhibition; and 3) to define the in vivo utility of co-targeting PD-L1 and mTOR to enhance CRC therapy.
The focus of this study is the innovative concept that both Snail and PD-L1 promote CRC progression by
cooperating with mTOR to modulate therapeutic response to mTORkis through dysregulation of 4E-BP1-
mediated translation initiation processes. This research will not only define the novel mechanistic roles of both
Snail and PD-L1 in the modulation of mTOR/4E-BP1-mediated translational control of CRC progression and
resistance to mTORkis, but also facilitate rational approaches for the development of new translatable
therapeutic strategies for patients with advanced CRC.

Public health relevance
PROJECT NARRATIVE Colorectal cancer is the second most common cause of cancer deaths in the United States for men and women combined, and approximately 40% of patients with this disease will eventually die of tumor metastasis. This proposal aims to deepen our understanding of signaling pathways and immune evasion mechanisms in metastatic colorectal cancer by taking a novel approach for investigating mTOR signaling biology and its deregulation in the molecular pathogenesis of this invasive disease, with the goal of identifying selective translational regulators as novel cancer therapeutic targets. This knowledge is expected to lay a foundation for the development of novel therapies for metastatic colorectal cancer, a goal with clear and significant implications for public health.